The role of extrachromosomal DNA in HER2-amplified breast cancer

PROJECT SUMMARY/ABSTRACT
Breast cancer is a major cause of morbidity and mortality in the United States and is the second leading cause
of cancer-related deaths among American women. Approximately 15% of newly diagnosed breast cancers in the
US contain amplifications of the HER2 oncogene (HER2+). These HER2+ breast cancers are notoriously
challenging to diagnose and treat due to their high levels of intratumoral heterogeneity, genome instability, and
tendency to develop resistance to targeted anti-HER2 therapies such as trastuzumab.
Extrachromosomal oncogene amplifications (extrachromosomal DNA or ecDNA) are increasingly appreciated
as drivers of poor patient outcomes in many different cancer types but their role in breast cancer pathogenesis
and the development of resistance to anti-HER2 therapy has yet to be explored. Furthermore, there are no
established experimental models for studying HER2 ecDNA amplifications in breast cancer. We recently found
that approximately one third of HER2 amplifications in breast cancer occur on ecDNA. We hypothesize that
HER2 ecDNAs contribute to the genome instability and development of treatment resistance in HER2+ breast
cancer, and therefore the identification of HER2 ecDNAs in breast cancer could be a clinically relevant finding.
In this proposal we will address the role of HER2 ecDNA in breast cancer pathogenesis and treatment response
using an innovative combination of patient samples, sequencing data, and organoid models. We will investigate
the role of HER2 ecDNA in driving transcription replication conflict and replication stress (Aim 1), the role of
HER2 ecDNA in the response to anti-HER2 therapies such as trastuzumab (Aim 2), and whether combined
targeting of HER2 and the S phase checkpoint improves the response to trastuzumab (Aim 3). The completion
of the proposed research will establish the role of ecDNA in HER+ breast cancer and establish breast cancer
organoids as a new experimental system for the study of ecDNA biology.
The applicant Natasha Weiser MD, PhD is a board-certified clinical pathologist at Stanford University with a world
class mentoring team of Dr. Howard Chang, an expert in RNA biology and epigenomics, Dr. Paul Mischel, an
expert in ecDNA, and Dr. Christina Curtis, an expert in breast cancer and organoid models. The proposal
encompasses a five-year plan to enhance her research and professional skills with the goal of launching her
independent career in academic pathology and cancer research. This award will facilitate the training required
to reach her long-term career goals of (1) establishing herself as a leader in the field of academic pathology, (2)
establishing a funded research program to understand ecDNA biology in the context of patient tumors, (3) being
an excellent mentor to future scientists and physicians.

Public health relevance
PROJECT NARRATIVE HER2-amplified breast cancer is a major source of morbidity and mortality among American women. We find that approximately one third of HER2 amplifications in breast cancer occur on extrachromosomal DNAs (ecDNAs), but the significance of HER2 ecDNA in breast cancer pathogenesis and treatment response has yet to be explored. This project will discover the role HER2 ecDNAs in breast cancer pathogenesis and response to targeted therapy and will identify therapeutic vulnerabilities in HER2 ecDNA-containing breast cancers to pave the way for improved prognosis and treatment for patients with breast cancer.